T32 for Training in Microbiology & Infectious Diseases

PROJECT SUMMARY
This proposal is the resubmission of the first competing renewal application for five years of funding to
support Training in Microbiology and Infectious Diseases at UC Irvine. The primary objective of this
Training Program is to provide doctoral students with integrated training in three focus areas: 1) microbial
structure and metabolism, 2) microbe-host interactions, and 3) microbial communities. The rationale
behind this training structure is that there will be tremendous value in individuals with fluency in these
related areas that are vital to combating and/or exploiting microbes to positively impact human health
and the environment. The Training Program will leverage areas of excellence at UCI in microbial
ecology, microbe-host interactions, and structural biology to bring together faculty trainers with expertise
in microbial pathogenesis, molecular genetics, metabolism, structure, immunity and infectious diseases,
and microbial diversity. The program will be comprised of 20 well-funded training faculty (9 women, 11
men, of which 3 are URM faculty) from the Schools of Biological Sciences, Medicine, and Physical
Sciences at UCI. The faculty mentors conduct research on microbiology and infectious diseases at the
molecular, cellular, organismal, population, and microbiome community levels. UCI has a strong history
in microbiology, infectious disease, and microbiome research. The Training Program will ensure that the
trainees will be equipped with the necessary tools and expertise to pursue a productive and independent
career in microbiology. In the renewal, there is a new emphasis in data science and bioinformatics to
reflect the evolving needs in the microbiology field. In addition to faculty mentorship, the trainees will
benefit from seminars, journal clubs, research in progress talks, an annual career panel, outreach
events, and an annual symposium. Trainees will also receive funds to travel to and present their
research at a national meeting in their field. Finally, UCI is home to the NIH-funded GPS-STEM program,
which will ensure that trainees have exposure to career development seminars, workshops, and
mentorship throughout their training. The renewal application requests support for four predoctoral
trainees, who will be drawn from students who enroll at UCI through one of several gateway or
departmental programs. In our last funding period, the mean GPA of appointed trainees was 3.90,
reflecting a strong overall academic performance by the potential trainees. All appointed trainees who
have graduated have remained in a science-related field. Notably, 66.7% of our trainees were URM
students during the last funding period. UCI has been recognized as a Hispanic-serving institution (HSI)
and an Asian American, Native American, and Pacific Islander serving institution (AANAPISI), and the
Training Program is expected to reflect this rich cultural and ethnic diversity on the UCI campus.

Public health relevance
PROJECT NARRATIVE This is the resubmission of the first competing renewal application for a T32 Training Program in Microbiology and Infectious Diseases at UC Irvine that will provide doctoral students with integrated training in three focus areas: 1) microbial structure and metabolism, 2) microbe-host interactions, and 3) microbial communities. The purpose of the Training Program is to train the next generation of promising scientists to tackle the myriad of scientific and health issues posed by microbes in the community and in infected individuals.